Intracellular Invasion by Streptococcus mutans: Significance in Disease

ABSTRACT
The human pathogen Streptococcus mutans is a major etiological agent associated in dental caries and a
common causative agent of infective endocarditis (IE). Evidence has recently emerged that strains of S.
mutans producing the collagen binding protein Cnm may be associated with more severe cases of IE and with
the development of other extra-oral pathologies including hemorrhagic stroke and IgA nephropathy. While
Cnm-producing strains are not prevalent in the oral cavity, crosss-sectional clinical studies have linked
infection with cnm+ S. mutans with increased caries incidence and severity. Moreover, studies conducted in our
laboratory have showed that S. mutans strains producing Cnm can more efficiently adhere to collagen-rich
tissues present in heart valves and in teeth (i.e. dentin) ex vivo, and are able to invade oral epithelial and heart
endothelial cells in vitro. Using the rabbit IE and rat caries models, we confirmed that Cnm is an important
virulence factor indicating that S. mutans strains that produce Cnm can be hypervirulent. The data obtained
thus far indicate that the properties conferred by Cnm enables S. mutans persistence and virulence in the oral
cavity that could also facilitate systemic dissemination and infection. Using molecular and biochemical
approaches, we found that Cnm is posttranslationally modified by a newly identified glycosylation complex that
was named Pgf. Loss of the Pgf system impaired Cnm function by affecting its stability. We also found that
Cnm has amylodoigenic properties albeit the impact of amyloid formation by Cnm on collagen-binding and
related functions is presently unknown. We propose that the glycosylation state and amyloidogenic form of
Cnm may contribute to its function by promoting protein stability (glycosylation) or by conferring novel
properties (amyloid formation) to Cnm. The overarching hypothesis of this application is that cnm+ S. mutans
strains are better equipped to colonize human tissues, including oral soft tissues and exposed dentin and teeth
roots, and, therefore may be associated with more aggressive and reincident cases of caries, such as those
found in early childhood caries. We postulate that oral infection by cnm+ S. mutans are linked to the most
aggressive cases of caries, as well as to caries recurrence that cannot be explained by conventional risk
factors such as high intake of sucrose-containing foodstuffs and poor oral hygiene. In this application, we will
use biochemical, molecular, glycoproteomic and structural approaches to characterize Cnm as both a
glycoprotein and an amyloidogenic protein, and the rat caries model to uncover the significance of Cnm in oral
colonization, persistence and cariogenicity. The findings of this study will reveal additional facets associated
with infection by different strains of S. mutans, which could lead to changes in current paradigms for assessing
caries risk and ultimately help devise novel antimicrobial therapies.

Public health relevance
Project Narrative Streptococcus mutans is a major etiological agent associated with caries and a causative agent of extra-oral infections such as infective endocarditis. In this application, we propose to use biochemical and genetic approaches to characterize a surface protein produced by S. mutans (named Cnm) that has been associated with both extra-oral and oral infections, and the rat caries model to determine the significance of Cnm in caries. These studies can facilitate the development of new products to prevent and treat dental caries as well as non- oral infections caused by S. mutans and other closely-related bacteria.